Scientific Information Management and Literature-Based Evaluations for the DTT - Novel Tools for Systematic Review Automation

New tool/method development is a critical component of DTTs scientific information management (SIM) for literature-based evaluation-related activities, necessitated by the volume of literature to review, complex designs and varying level of reporting of research studies in the literature, and the need to prepare high quality text and graphics necessitate these activities. This project focuses a robust effort on the development of automated processes that can increase efficiency.
Keywords: Systematic review, publication